Phage resistance and mobile genetic elements in Vibrio cholerae

Waterborne pathogens like Vibrio cholerae pose significant threats to global health. V. cholerae can persist in
the aquatic environment, and it can emerge to cause devastating cholera outbreaks in endemic regions and
vulnerable areas lacking adequate water and sanitation infrastructure. The host-pathogen interactions that
dictate disease outcome and cholera transmission dynamics occur in the context of a complex microbial
ecosystem that includes predatory bacterial viruses (phages). Phages profoundly impact the evolution of their
bacterial hosts, both through predation, which selects for hosts with defenses that overcome phage killing and
through mobilization and dissemination of genetic material. Certain mobile elements called the phage satellites
have evolved sophisticated mechanisms to exploit phages for their own selfish spread. Such elements interfere
with the replication of the phages they parasitize, and as such, provide their cellular hosts with a means to limit
phage predation. Our lab discovered PLEs (for phage-inducible chromosomal island-like elements) in V.
cholerae that provide specific and robust defense against ICP1, the dominant lytic phage co-circulating with V.
cholerae in cholera endemic regions. Upon infection by ICP1, PLEs excise from the V. cholerae chromosome,
replicate to high copy and are assembled into virions to spread the PLE genome to new cells while
concurrently abolishing phage production. PLEs are uniquely potent, highly specific, anti-phage barriers that
act through multiple mechanisms to ensure that ICP1 does not propagate and spread to neighboring V.
cholerae cells. However, few mechanisms of direct interference with ICP1 are known, and none are essential
for PLE activity, indicating that additional mechanisms await discovery in this system. This proposal builds on
our prior work defining the PLE lifecycle in response to phage infection to gain a mechanistic understanding of
how PLEs execute their unusually potent anti-phage activity. Our data indicate that PLE’s most potent anti-
phage inhibitors are focused on blocking virion assembly. To understand PLE activity in mechanistic detail, we
will pursue the following specific aims: 1) We will define the structural composition of virions and capsid
assembly intermediates for ICP1 and PLE 2) We will Interrogate the functions of three PLE-encoded ORFs that
are each sufficient to inhibit phage 3) We will determine how a PLE-encoded small RNA perturbs phage gene
expression. The proposed studies are expected to reveal novel mechanistic paradigms not previously
documented in phage satellites or other anti-phage defense systems. The long-term coevolution of V. cholerae
PLE and ICP1 serves as a powerful model system to understand clinically relevant phage defense
mechanisms to inform phage therapy efforts and understand the forces driving the evolution of bacterial
pathogens.

Public health relevance
PROJECT NARRATIVE Facultative pathogens like Vibrio cholerae must defend against the ubiquitous threat of predatory phages to cause disease in humans. This proposal aims to determine the molecular basis for the anti-phage activity of a group of mobile genetic elements in epidemic V. cholerae. Advances in our understanding of factors impacting microbial survival in states of disease will contribute to improved and targeted infection control measures.